USE OF GROWTH HORMONE FOR OSTEOPOROSIS OF WERNERS SYNDROME

The purpose of this project is to study the value of the administration of recombinant human growth hormone in the treatment of severe osteoporosis in a patient with Werner's Sundrome and growth hormone deficiency.